CORE--STATISTICAL AND COMPUTER SERVICES

The Administrative/Statistical Services Core has five main functions: (1) to facilitate scientific and administrative communication among the Project participants. (2) to manage the central data archives and facilitate exchange of verified data among projects. (3) to provide major statistical guidance for subproject 00021 and for between level analyses. (4) to coordinate statistical services and consultation for the participating investigators. (5) to provide unified administrative services to each of the components of the Project. Specifically, subproject 9001 will provide for means of effective scientific communication among the several investigators, will provide and maintain resources for data management and analysis serving the five projects and will provide the technical services needed to assure that all administrative requirements of the Project can be effectively fulfilled. A central database will be constructed to include data from each of the projects including behavioral, event-related potential. Magnetic resonance imaging, functional magnetic resonance imaging, and cytoarchitecture measurements. In addition, facilities will be provided to assure the safe and accessible retention of all "raw" data from which the database data is derived. Database connectivity between investigators and consultants at disparate sites is available via Timbuktu software.